Administrative Core

Project Summary
The Administrative Core will provide central coordination and administration for the entire program. It will
maintain all documentation pertaining to budgets and regulatory matters. The core will coordinate i) activities
with administrative staff responsible for the conduct of the program at the partner institutions, ii) timely and
accurate reporting on scientific progress to the NCI and financial matters, iii) semi-annual internal advisory board
(IAB) meetings, iv) monthly Data Clubs, v) regularly scheduled and ad hoc P01 leader meetings, and vi) a yearly
workshop including the External Advisory Board (EAB) members. The core will maintain records pertaining to all
IACUC protocols, IRB protocols, publications, and meeting minutes and reports. The core will also incorporate
a bio-statistician who will perform statistical analyses and design studies with statistical rigor in mind to
maximize the power and resource utilization in all projects and cores, and make sure that P01 samples are
processed in a timely manner. The core will be in charge of coordinating the exchange of information between
the Projects and the Shared Resource (SR) Core through a shared Box Drive, maintaining all of the data
generated by the P01, ensuring that all human specimen and mouse requests and studies are accounted for
understanding IACUC and IRB protocols. Data sharing is an important aspect of this program since datasets
analyzed by each project is of interest to the others, the Administrative Core will help to ensure that all
projects can access and share datasets and protocols in the shared drive and the data are organized suitably
and have appropriate metadata tags. Because the Administrative Core will be the central nexus in the web of
collaborative sharing of samples and data, it provides essential and equal support to all three projects and the
SR Core.

Public health relevance
Project Narrative The success of a P01 grant is dependent on the integration of the projects and Shared Resources Cores. The Administrative Core proposed in this P01 grant will provide a framework of interaction and collaboration as well as a regular evaluation of progress and an opportunity for early corrective actions, if necessary, that will foster the scientific and translational objectives of the individual projects and the P01 as a whole and help achieve the overall goal of the P01, which is to investigate novel mechanisms underlying cancer resistance to ferroptosis and how these mechanisms can be exploited for the development of novel ferroptosis-based cancer therapies